COBRE for Women in Science & Engineering on Osteoarthritis

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Knowing the biology underlying OXT clearance and its association with disease progression will help researchers understand disease etiology and lead to clinical translation of key findings.